Building Knowledge About Alternatively-spliced Dual-Coding Exons

Abstract
Most protein-coding genes in humans and other eukaryotes are made up of a collection of exons,
which are concatenated to form the messenger RNA (mRNA) that encodes a final protein
product. The well-known phenomenon of alternative splicing makes it possible for a single gene
to encode multiple protein products, by conditionally including only a subset of the gene’s exons
into the expressed mRNA. A more surprising mechanism for producing alternate protein products
is to utilize an alternate reading frame of a standard exon, through aberrant splicing; using
custom software built in our research group, we have found that this mechanism appears to be
quite common. Specifically, ~13% of all human genes include at least one exon that conditionally
encodes alternate peptides, and these “dual-coding exons” are highly-conserved: 98%
correspond to homologous exons in the mouse genome that also encode two open reading
frames. Light exploration has identified dozens of human genes that show tissue-specific
patterns of reading frame usage, suggesting a functional role for at least some of these variants.
Here, we describe a plan to (i) leverage massive public atlases of human tissue-specific and
development-specific RNA-Seq and mass spectrometry data to tabulate the extent of differential
use of these frame-shifted splicing variants, and to (ii) analyze the computationally-predicted
structural and functional impact of dual-coding variants, and the sequence signals controlling
them. The results of these analyses will be accumulated for release in an open and accessible
web service.

Public health relevance
Narrative We have found that ~13% of all human genes include at least one exon that can (and apparently does) encode two distinct peptides, depending on condition-specific splicing activity. These surprisingly prevalent human dual-coding exons nearly all show similar dual-coding nature in the mouse genome – this extent of conservation strongly suggests that they play an important biological role. Here, we describe a plan to catalog the tissue- and development-specific splicing patterns of dual-coding variants, and to computationally explore their mechanisms of control and expected functional impact. This work will establish a robust repository of analysis of this exciting and poorly understood mode of controlling gene function and activity, and will lay the groundwork for its future study.